Essential role of the cyclin-G associated kinase (GAK) in diffuse large B-cell lymphoma progression

Project Summary/Abstract. Diffuse large B-cell lymphoma (DLBCL) is the most frequently diagnosed lym-
phoma and carries poor prognosis for the ~40% of patients not cured by frontline therapy. While emerging im-
munotherapies provide new options for relapsed or refractory (rel/ref) patients, kinase inhibitors have found
little role in DLBCL management despite transformational impact on other lymphomas. In this proposal, we de-
fine the cyclin-G associated kinase (GAK) as a novel therapeutic target, discovered through phenotypic
screening and machine-learning target deconvolution. We find GAK is a cell-cycle kinase critical for mitotic
spindles. DLBCL tumors with reduced function of the tumor suppressor retinoblastoma (RB) in particular show
critical dependence on GAK. Preliminary data also demonstrate in vivo efficacy of GAK inhibition against
DLBCL xenografts, employing a pharmacologically unfavorable tool compound. To leverage this discovery to
rapid evaluation in rel/ref patients, we found clinically available kinase inhibitors with strong anti-GAK activities
suitable for repurposing. Several of these have stronger activity against GAK than their primary clinical targets
and demonstrate potent killing of DLBCL tumors. We also reveal phosphoproteomics that implicate for the first
time direct substrates by which GAK regulates mitosis. Our central hypothesis is that rapidly dividing DLBCL
cells require GAK’s phosphorylation of specific mitotic regulators for successful nucleation and positioning of
mitotic spindles. To test this, we pursue three specific aims. Aim 1 assesses microscopically the context and
mechanisms GAK kinase regulation of mitosis. Confocal microscopy optimized on a high-throughput live-imag-
ing platform seek to define specifically the role of GAK kinase activity in mitosis and the mechanistic basis for
increased GAK dependence in RB-deficient tumors. Aim 2 defines biochemically and functionally GAK’s phos-
phorylation substrates that regulate mitosis. Substrates to be evaluated biochemically and functionally include
MTUS2, CENPF, EZRIN, and other candidates from our preliminary data. Aim 3 evaluates anti-lymphoma effi-
cacy and hematologic toxicity of GAK inhibition in vivo. Inhibitors of other mitotic kinases like Aurora kinase A
have been plagued clinically by hematologic toxicities. Here, using complementary murine lymphoma models,
we pursue a hypothesis that GAK inhibition will be efficacious at reduced toxicity. Moreover, results are de-
signed to directly inform development of investigator initiated trials (IITs) of repurposed compounds from this
project co-led by a lymphoma physician-scientist. We expect to define GAK – never before studied as a can-
cer therapeutic target – as a critical dependency for mitosis by DLBCL. We both investigate mechanisms and
rigorously determine GAK’s suitability as a novel clinical target. Our project is innovative because we show for
the first time GAK is a mitotic kinase and the experimentally generated phospho-substrates by which it carries
out these activities. Our project is significant because unmet clinical need remains persistently high for rel/ref
DLBCL patients, and RB deficiency is a common, high-risk, and currently untargetable biomarker in patients.

Public health relevance
PROJECT NARRATIVE The proposed research impacts public health because better comprehension of the biology of aggressive B-cell lymphomas is needed to develop new treatments for patients affected by these common and deadly cancers. Specifically, we focus on understanding how a specific protein called the cyclin-G associated kinase (GAK) drives progression of these diseases. The project is relevant to the NCI’s mission because we expect results to deter- mine GAK’s suitability as a therapeutic target with potential to open new treatment strategies able to improve patient outcomes.